Oxygen, Pulmonary Innate Immunity and Alveolar Epithelial Cell GM-CSF

Pulmonary innate immune responses depend upon a highly regulated multicellular network to defend
an enormous surface area of interaction with the external world. Disruption of these responses renders the
host susceptible to pneumonia and subsequent systemic spread of infection. This proposal is to investigate
the impact of local variation in oxygenation within the lung on key aspects of this host defense network.
Heterogeneous ventilation is a common feature of many pulmonary conditions, including fibrotic lung diseases,
COPD, and pneumonia and especially the acute respiratory distress syndrome (ARDS), resulting in regional
hypoxia. Alveolar epithelial cells are key participants in this innate immune network. Prior work from this
laboratory determined that hyperoxia, a biologically relevant form of oxidative stress, results in specific
suppression of alveolar epithelial cell expression of granulocyte-macrophage colony stimulating factor (GM-
CSF), leading to alveolar macrophage dysfunction and increased susceptibility to lethal pneumonia. The
mechanism of this suppression involves accelerated mRNA turnover due to induction of specific microRNA in
alveolar epithelial cells. In preliminary studies for this application we have found that hypoxia has a profound
but very different effect on alveolar epithelial cell (AEC) innate immune function. Exposure to an atmosphere
of 1% oxygen results in significant suppression of primary murine AEC expression of key innate immune
molecules including GM-CSF, CCL2 and IL-6, without inducing cellular injury. In parallel, hypoxia also leads to
diminished phagocytosis and expression of key mediators by inflammatory macrophages, suggesting that
hypoxia causes a broad depression of pulmonary innate immune responses. Using GM-CSF in AEC as a
prototype, we found that mRNA turnover was not altered in hypoxia, but that transcription was greatly
decreased, as was accessibility of the proximal promoter region of the GM-CSF gene. We also found that NF-
kB activation was decreased in AEC exposed to hypoxia, perhaps explaining the effects of hypoxia on a range
of innate immune mediators. This novel finding is in contrast to observations in many other cell types in which
hypoxia induces NF-kB activation, emphasizing the importance of cell specificity for these responses. Finally,
mice exposed to hypoxia for 48h demonstrate greatly reduced expression of GM-CSF mRNA and protein in
lung homogenates, in association with impaired alveolar macrophage function. The macrophage defect was
reversed by in vivo treatment with GM-CSF. This application is based on the central hypothesis that regional
hypoxia in the lung leads to suppression of local host defense, resulting in increased susceptibility to, and
delayed clearance of, pneumonia. We will explore this hypothesis in experiments with three Specific Aims that
progress from primary AEC, to multicellular networks, to animal models. Specific Aim 1 will determine the
mechanisms by which hypoxic conditions in vivo suppress lung expression of GM-CSF, AM phagocytosis and
bacterial clearance. Experiments for this aim will confirm the central role of GM-CSF in the hypoxia-induced
defect in host defense and elucidate the contributions of hypoxia inducible factors (HIF), and inducible nitric
oxide synthase (iNOS) to suppression of NF-kB activation and GM-CSF expression. Specific Aim 2 will
determine the molecular mechanisms by which hypoxia suppresses AEC innate immune responses. Focusing
on GM-CSF expression, work in this specific aim will determine the contributions of HIF-activation, NO-
mediated changes in NF-kB signaling and ATP-induced changes in chromatin remodeling. Specific Aim 3 will
determine the effects of hypoxia on local innate immune defenses in vivo, using mechanically ventilated lambs
demonstrating regional hypoxia in the lung. When successfully completed, this work will address important
questions related to the contribution of local hypoxia to vulnerability to pneumonia and will suggest novel
opportunities for therapeutic intervention.

Public health relevance
Pneumonia is a major cause of morbidity and mortality in the Veteran population. This project will investigate a novel mechanism potentially contributing to the risk of developing pneumonia and impaired resolution of pneumonia in this population. Many lung diseases that are common in Veterans, including chronic bronchitis and emphysema, pulmonary fibrosis, heart failure, the acute respiratory distress syndrome and pneumonia itself are associated with regions of the lung that receive inadequate oxygen. Preliminary data for this proposal have demonstrated that inadequate local oxygen levels lead to suppression of expression of critically important molecules responsive for defense against pneumonia by the alveolar epithelial cells that line the lung. The studies proposed in this Merit Review application will provide new insights into the effects of variation in local oxygen availability on pulmonary host defense and will offer new approaches for therapeutic interventions to prevent or alleviate pneumonia in individuals with other lung diseases.